Acquisition of a 400 MHz NMR Spectrometer

Project Summary
NMR spectroscopy has revolutionized the identification and study of molecules relevant to
human health. Within this technique, the needs of individual research groups can vary widely,
necessitating support by versatile NMR spectrometers capable of serving diverse research
programs. We propose the acquisition of a new 400 MHz spectrometer and associated
autosampler to replace an antiquated (ca. 20 years old) but heavily relied-upon instrument in the
Small Molecule NMR facility at Vanderbilt University. The proposed instrument includes a modern
console and 5 mm BBFO probe for the observation of nuclei ranging from 1H (400 MHz) to 109Ag
(19 MHz) as well as variable temperature capability in the range of -150 to +150 °C. This
instrument will support research groups engaged in cutting-edge research in the chemical and
biochemical sciences at Vanderbilt University including efforts in small molecule total synthesis,
glycoscience, catalysis, C-H activation, and natural products discovery, representing the diversity
of needs for NMR capabilities in the modern biomedical sciences.
The Small Molecule NMR facility at Vanderbilt has a long history of effective management and
maintenance of its spectrometers, but they are now approaching the end of their service life. At
the same time, a new cohort of young investigators are advancing research programs that
demand new capabilities. The primary motivation for this instrument request is a need for
enhanced heteronuclear NMR spectroscopy at Vanderbilt University. Contemporary research
efforts now requite routine and walk-up access to 1H, 11B, 15N, 19F, and 31P NMR and associated
two-dimensional experiments which our antiquated instrumentation is insufficiently equipped to
provide. High-sensitivity electronics and a new 60-position autosampler capable of safely handling
small volume, gas-tight, and screw-capped NMR tubes will support the increasing demand for
experiments outside of the traditional paradigm of routine 1H and 13C NMR on abundant, air-stable
small molecules, for instance, high-throughput 19F and 15N NMR on dilute samples.
In total, this proposal will modernize the capabilities of the Small Molecule NMR facility at
Vanderbilt University and empower next-generation research programs with new and needed
tools in proton and heteronuclear NMR spectroscopy.

Public health relevance
Project Narrative NMR spectroscopy provides a means to identify, observe, and study the interactions of molecules important to human health. The proposed acquisition of a new spectrometer at Vanderbilt University will support researchers in the chemical and biochemical sciences who are working to identify natural products, advance drug candidates, understand the toxicity of chemotherapeutics, and develop molecular probes. This new instrument will modernize NMR infrastructure on campus and assist in training a new generation of chemists and chemical biologists.